Studying the Genetics of Aging, Behavioral, and Social Phenotypes in Diverse Populations

Project Summary/Abstract
For this application, “Studying the Genetics of Aging, Behavioral, and Social Phenotypes in Diverse Populations,”
we propose to develop tools to promote genetic research of aging, behavioral, and social phenotypes in
diverse populations. These phenotypes have a number of unique characteristics (e.g., polygenicity,
environmental mechanisms, and small effect sizes) which require special consideration when developing
research tools. In brief, we propose to:
• Develop the Genetic-Related-Matrix-Matched Association study (GRMMA) tool for performing
genome-wide association studies (GWASs) in large, diverse data sets. Current GWAS methods require
restricting samples into approximately homogeneous-ancestry samples, which is wasteful and has
resulted in Eurocentric bias in genetics research. Using matching methods, GRMMA can use more of the
available data in a way that both reduces bias and increases statistical power. We will employ
computationally efficient strategies that allow us to implement GRMMA in large diverse sample such as
the UK Biobank. We will make the GRMMA tool and tutorials publicly available through the online
repository, Github.
• Develop SBayes-Universal (SBayesU), an efficient new tool for producing polygenic scores (PGSs) by
optimally combining GWAS summary statistics estimated in different populations. The key feature of
SBayesU is that it uses a low-dimensional eigen decomposition of the linkage disequilibrium matrix.
This permits SBayesU to model a much larger set of SNPs, to model SNP annotations, to account for
imperfect cross-ancestry genetic correlation, to produce PGSs for populations that are not included
among the sets of GWAS summary statistics, and to allow our algorithms to converge much more
quickly and reliably. We will also make the SBayesU tool and tutorials publicly available.
• We will apply the best available method for producing diverse-population PGSs (which we anticipate
will be SBayesU) to a wide range of aging, behavioral, and social phenotypes, using existing cohorts and
new genotyped data that becomes available during the grant period. We will make the polygenic scores
we produce publicly available as part of the Social Science Genetic Association Consortium’s Polygenic
Index Repository, which currently creates polygenic scores for 11 widely used datasets (but currently
only for the European-ancestry individuals in those datasets). Each release of the Repository will be
accompanied by documentation that clearly describes methods used and the underlying data.

Public health relevance
Project Narrative This project aims to develop tools to promote genetic research of aging, behavioral, and social phenotypes in diverse populations. Existing comparable tools require that researchers omit some data when those data come from diverse populations, whereas our proposed tools account for population differences in a way that allows researchers to use much more data in more diverse samples. Using these tools, we will be able to make scientific discoveries that are more representative of the global population, which will reduce the potential for unequal benefits from genetic research.